14th Hershey Developmental Brain Injury Conference

PROJECT SUMMARY/ABSTRACT
The Hershey Conference on Developmental Brain Injury was started in 1997 and has grown to a high-quality
program that attracts international attendees that include physician-scientists, basic scientists, and trainees. The
conference is held every other year, and the site alternates between international and US locations. Sessions
include invited speakers who are luminaries in the field, as well as sessions in which more junior investigators
share their work. This conference offers an amazing opportunity for trainees and young investigators to meet
and interact with senior investigators in the field in a relaxed environment. The scientific presentations are always
outstanding. The 2024 14th Hershey Conference organized by Drs. Henrik Hagberg and Carina Mallard (together
with an international scientific committee) will be held in Marstrand close to Gothenburg on the Swedish west
coast, at the Marstrands Havshotel. We are applying to NIH for support primarily to fund attendance for junior
investigators and trainees from the US. The overall goal of the proposed meeting is to bring together an
international group of scientists whose focus is on neonatal brain injury and repair. This year's overarching theme
will be: Perinatal Brain Injury including mechanisms, experimental models, neuroprotection,
biomarkers/machine learning and long-term outcome. This three-day meeting will include the following
sessions: Long-term outcome and retinopathy of prematurity; Experimental models of perinatal brain injury;
Neuroprotection; Mechanisms of brain injury; biomarkers and machine learning. The meeting has four objectives:
1) To identify clinical paradigms that inform basic science concepts and translate those new basic concepts into
more refined clinical application
2) To explore areas of gaps in our current knowledge, and to include experts in tangential fields to provide new
perspectives on these gaps
3) To promote novel collaborations
4) To promote trainee and junior faculty participation and to identify trainees/junior faculty from racial/ethnic
minorities and underrepresented institutions to attend this conference and develop new collaborations.
In summary, the objective of this R13 is to provide the necessary continued support for trainees and junior faculty
from US to attend the 14th Hershey Conference on Developmental Brain Injury in Europe. Extensive participation
of trainees, both from US and abroad, has been a hallmark of the Hershey Conference. Trainees, both MD and
PhD, constitute 30-40% of all participants. This meeting provides an excellent opportunity for informal interaction
between trainees and the leaders in the field as well as a mechanism for post-doctoral and visiting scientist
recruitment. Past meetings have been an inspiration for young researchers to pursue the field of developmental
neuroscience.

Public health relevance
PROJECT NARRATIVE Neonatal brain injury remains the most common cause of infant mortality and morbidity in infants and children and is a tremendous public health problem. The Hershey Conference on Developmental Brain Injury brings together an international group comprised of leaders in this field, esteemed scientists from outside but related fields, as well as a high proportion of young trainees to continue the important discussions and dissemination of information constantly geared towards finding new and better modes of intervention and neuroprotection.